Analysis of Lipolytic Trafficking in Adipocytes

? DESCRIPTION (provided by applicant): ABHD5 is an important lipase-activating protein, but how it functions to control lipolysis is poorly understood. Screening of the NIH compound library identified compounds that directly bind and activate ABHD5 independently of known extracellular signaling pathways. By using these probes in molecular imaging assays, we discovered endogenous ligands that bind ABDH5 and regulate its lipase-promoting activity. This proposal will investigate this novel locus of lipolysis control using integrated cellular and molecular approaches. A greater understanding of how these endogenous and synthetic compounds regulate ABHD5 could lead to novel therapeutics for treatment of obesity-related disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will investigate how proteins regulate intracellular lipolysis. We have identified a novel mechanism for regulating lipolysis in fat and muscle. We have identified endogenous and synthetic chemicals that can activate or inhibit a specific lipase-activating protein. We will determine the cellular consequences of modulating this pathway, and determine how these chemical signals work at a molecular level. The long-term goal is discover novel targets for treating obesity-related disorders.